Computation/Statistics

Abstract – Computation and Statistics Core 002
Our Center proposes to have a Computation and Statistics Core intended to provide scientific support to both
human and animal research projects. This Core will provide four services to the program team, and also
disseminate our technology and generated data to the neuroscience community in general. The first service will
be to provide exceptionally high quality acquisition and preprocessing protocols for brain imaging datasets, as
well as to introduce new technical advances in the area. Human and rodent brain imaging data processing are
complicated and require continued vigilance for proper assessment of quality of collected data, preprocessing of
data, and proper selection and application of data analysis methods and tools. Separate pipelines will be provided
for rodent and human data preprocessing, segmentation, registration to standard atlases, and advice will be
provided for design and processing of collected data. This service will be used by Project 1 for human and rodent
brain imaging data. The second service will be to provide advice and statistical tools for experimental design and
data analysis to both our internal team members at the neuroscience community at large. The service will help
ensure proper blinding of collected data, predetermining of group sizes based on power calculations. The third
service will aid researchers in the design and implementation of multi-parameter statistical regression and
Bayesian models of human and animal data, especially when combining multi-modal observations. Again, these
services will be provided to all four projects as well as the broader scientific community. The fourth service will
be disseminating our brain imaging techniques and collected data to the scientific community through our
OpenPain portal, and also contacting other groups to encourage them to post their fMRI data on OpenPain, from
studies that are already published and were funded through NIH grants, both human and rodent. Baliki and
Griffith will lead this Core jointly. Dr. Baliki is a young scientist with extensive expertise in fMRI data analyses
methods and in advancing these techniques. Dr. Griffith has expertise is human and behavioral data and has
worked with the Apkarian group for many years in the capacity of statistical consultation and analyses. They will
also oversee other technical staff involved in organizing OpenPain. The datasets and associated methods and
software will provide valuable resources for characterizing human and rodent brain function, and their
relationship to behavior.